Glucagon-mediated glycemic effect in humans with and without rerouted gut after bariatric surgery

Glucagon plays an important role in glucose physiology, but the full range of its hormonal actions in humans is
not completely understood. Gastric bypass surgery (GB) and sleeve gastrectomy (SG) induce durable weight
loss and reverse type 2 diabetes. The glycemic effects of GB and, to lesser degree, SG is associated with
much faster nutrient emptying from stomach pouch/stomach to the gut resulting in larger glucose excursion
and lower nadir glucose levels as well as greater insulin and proglucagon peptides (glucagon-like peptide 1
[GLP-1] and glucagon) secretion. The glycemic effect of GB is exaggerated in a subgroup of patients who
develop a devastating complication of hypoglycemia after this surgery. Dysregulated glucagon response to
meal and hypoglycemia is well documented after GB and SG. However, the glycemic effects of
hyperglucagonemia during prandial hyperglycemia or the hepatic action of glucagon during hypoglycemia or
hyperglycemia in absence of nutrient stimuli after these procedures is largely unknown.
We have previously found that prandial counterregulatory glucose response to hypoglycemia induced by
supraphysiological insulin doses is impaired after GB or SG despite hyperglucagonemia. Therefore, we
hypothesize that hepatic action of glucagon during both hypoglycemia or hyperglycemia under physiological
conditions is smaller in GB and SG compared to non-operated controls (CN), particularly in post-GB
hypoglycemic patients. We test this hypothesis in Aim 1 by measuring the effect of exogenous glucagon
infusion during pancreatic clamp producing hyperglucagonemia that mimics prandial glucagon profile of GB or
SG on endogenous glucose production during separate hypoglycemic and hyperglycemic conditions in
absence of meal stimuli. Further, recent studies in rodent models have suggested that glucagon is essential in
nutrient-induced insulin secretion or insulin action via glucagon or GLP-1 receptor. Therefore, it is conceivable
that improved glucose tolerance and prandial hyperinsulinemia after bariatric surgery that previously attributed
to GLP-1R signal can also reflect insulinotropic effect of hyperglucagonemia after GB or SG. We test this
hypothesis in Aim 2 by measuring post-mixed-meal glycemic effects of disrupted glucagon signal by
administration of glucagon receptor antagonist (REMD-477). We expect a larger glycemic effect, mediated by
insulin secretion or action, after GB and SG, particularly in those with GB-related hypoglycemia.
Four groups of subjects will be studied: patients with GB-related hypoglycemia, asymptomatic GB and SG
individuals, and non-operated controls. The PI has considerable experience in conducting clinical trials in these
cohorts. Physiological insights into glucagon action in humans is critical in guiding glucagon-based drug
development to treat hypoglycemia and hyperglycemia. Also, understanding of glycemic effects of bariatric
surgeries based on glucagon action is critical for development of personalized therapeutic options to optimize
antidiabetic effects of GB or SG and mitigate glucose abnormalities, such as post-bariatric hypoglycemia.

Public health relevance
Narrative Glucagon plays an important role in glucose, lipid and amino acid physiology but the full range of glucagon’s physiologic actions in humans is still not established. Bariatric surgery, which is still the most effective treatment for obesity and diabetes, alters glucagon response to meal ingestion as well as counterregulatory response to hypoglycemia. This project will use a combination of gain- and loss-of-function mechanistical design to examine the glycemic actions of glucagon in both postprandial and fasting conditions in humans with and without bariatric surgery.